Immune-Related Adverse Events in Melanoma Patients Receiving Adjuvant Immune Checkpoint Inhibitor Therapy

PROJECT SUMMARY: Immune checkpoint inhibitors (ICIs) have transformed the treatment of melanoma, significantly
enhancing overall survival. The exponential increase in their use after being approved for melanoma in the adjuvant setting
is significantly changing the lanscape of cancer survivorship. Inspite of the survival benefits, the use of ICI can be limited
by off-target inflammatory responses and autoimmunity in various organs. The clinical phenotypes of the acute immune
toxicities have been clearly documented in trials. Yet, their potential long-term adverse effects, and their impact quality of
life (QOL) are still undetermined. The overall goal of the proposed study is to understand the full impact of adjuvant ICI
therapy, including its potential toxicity/symptom burden and its immune correlates in melanoma patients receiving regular
clinical care. We hypothesize that: adverse events and sustained inflammation induced by adjuvant ICIs increase symptom
burden and negatively impact function and QOL in a subset of melanoma patients receiving therapy, and that elevated
expression of pro-inflammatory cytokines and T-cell signatures during therapy correlate with the toxicity and symptom
burden. We will test this hypothesis in a prospective cohort of 240 melanoma patients from the initiation of adjuvant ICI
therapy through 2 years of follow-up. We will determine the incidence, clinical phenotypes, timing, and severity of irAEs,
and will longitudinally assess patients reported outcomes through 2 years of follow-up. We will use validated instruments
and ecological momentary assessments technology to assess adverse events and symptom burden in real time via patient-
initiated reports. Lastly, we will characterize patient immune signatures (immune cell phenotypes and inflammatory
cytokines) from baseline through 2 years of follow-up and evaluate their association with irAEs and symptom burden.
CAREER DEVELOPMENT PLAN: The primary objective of this application is to support Dr. Abdelwahab’s career
development into an independent immuno-epidemiologist with a focus on autoimmunity arising in the context of cancer or
its therapy. Dr. Abdelwahab proposed training in four areas 1) immunology, 2) epidemiology and biostatistics, 3) health
services and outcomes research, and 4) scientific writing and oral presentations. Dr. Abdelwahab has assembled an
outstanding mentorship team led by Dr. Cassian Yee, Professor in Melanoma Medical Oncology and Director of Solid
Tumor Cell Therapy in the Center for Cancer Immunology Research, and Dr. Annemieke Kavelaars, Professor in Symptom
Research at MD Anderson Cancer Center (MDACC) as co-primary mentors. This is complemented by mentoring advisory
committee members including Dr. Adi Diab, Associate Professor in Melanoma Medical Oncology with expertise in tumor
immunology and immunotherapy, Dr. Suarez-Almazor, Professor of Rheumatology and Clinical Immunology, Dr. Susan
Peterson, Professor in Behavioral Science and Director of the Assessment, Intervention and Measurement Facility, and Dr.
Sanjay Shete, Chief of Behavioral and Social Statistics. MDACC, a leading center in cutting edge of cancer research, care,
and prevention, is an excellent training environment for Dr. Abdelwahab.

Public health relevance
PROJECT NARRATIVE In this proposal, we will prospectively evaluate the immune-related adverse events, symptom burden, and immunological correlates in patients receiving adjuvant therapy with immune checkpoint inhibitors in clinical practice. The study will use validated patient reported outcomes and ecological momentary assessments method that have not been reported before in this setting. Our findings will inform recommendations on clinical assessments and management of toxicity and symptom burden, risk-benefit considerations, and provide a solid foundation for further translational and clinical research in this area.